The Impact of Structural Racism on Racial/Ethnic Disparities in End-Stage Kidney Disease from Healthy Population to Mortality

Project Summary
Racial disparities in the incidence and treatment of end-stage kidney disease are well-documented and largely
consistent across outcomes, and an emerging consensus indicates that these disparities are likely to be
primarily driven by structural racism (SR). Non-Hispanic Black, Hispanic persons of any race, and American
Indian or Alaska Natives (AIAN) are a) at higher risk of chronic kidney disease (CKD) throughout their life
course; b) more likely to progress from CKD to end-stage kidney disease (ESKD); c) less likely to be referred for
kidney transplantation; d) less likely to obtain a living donor kidney transplant (LDKT); e) experience higher
mortality hazards on the transplant waiting list and post-transplant; and f) experience higher rates of post-
transplant graft failure. The major exception to this rule is the higher survival rate of Black and Hispanic ESKD
patients on dialysis. For all other outcomes, the consistency with which highly similar disparities are observed
across these disparate processes suggests that deeper mechanisms are at work — i.e., SR. To assess the hidden
forces of SR underlying consistent disparities in ESKD, we will analyze a very large health survey linked to
longitudinal Medicare claims, geospatial information, and mortality outcomes. Our approach to measuring SR
will be multidimensional, capturing local racial/ethnic inequalities in economic, educational, judicial, political,
and residential outcomes as well as health care affordability, contact, proximity, and quality. Furthermore, to
fully reflect the contribution of divergent medical treatments to racial/ethnic disparities in ESKD patient
outcomes, we will measure ESKD patients’ treatments over time, then identify the most important treatment
trajectories for racial/ethnic disparities. In our Aim 1 analysis, we hypothesize that non-Hispanic Black,
Hispanic, and AIAN individuals will have higher risk of ESKD development, and that SR will significantly
explain these disparities. We will test this hypothesis by analyzing restricted Medicare claims and geospatial
data linked to the National Health Interview Study (NHIS; 1994-present; N=941,492 Medicare-linkage-eligible
respondents). In our Aim 2 analysis, we hypothesize that non-Hispanic Black, and AIAN respondents will be
less likely to receive optimal treatment trajectories and more likely to receive suboptimal treatment trajectories
than non-Hispanic Whites. We will construct treatment trajectories using sequence analysis techniques, and
assess racial/ethnic disparities in treatment trajectories in the United States Renal Data System dataset
(USRDS; 1997-2018; N=2,335,340). In our Aim 3 analyses, we investigate whether racial/ethnic ESKD patient
survival advantages compared to non-Hispanic Whites are modified by SR and treatment trajectories. We
hypothesize that SR and treatment trajectories both modify racial/ethnic disparities in ESKD patient
outcomes, but that treatment trajectories will offer the greatest explanatory power due to their more proximate
relationship to patient outcomes. We will test this hypothesis by assessing how well each characteristic
statistically explains racial/ethnic disparities in ESKD patient mortality. Throughout the research process we
will work with two established community advisory boards to generate novel ideas for analyses, results
interpretation, and specific proposed interventions, and refine the proposed interventions for future testing
with input from the board and ESKD health care professionals.

Public health relevance
Project Narrative Racial disparities in the incidence and treatment of end-stage kidney disease are well-documented and largely consistent across outcomes, and an emerging consensus indicates that these disparities are likely to be primarily driven by structural racism (SR). We will develop theoretically-driven, innovative measures of SR using restricted microdata and other sources, analyze the role of SR in racial/ethnic disparities in end-stage kidney disease incidence and mortality outcomes, determine how best to operationalize meaningful racial/ethnic disparities in sequences of kidney disease therapies, and work with two established community advisory boards to develop proposed interventions to ameliorate racial/ethnic disparities in kidney disease on the basis of our findings.